Regional monitoring of CF lung disease after changes in mechanical airway-clearance treatment

PROJECT SUMMARY
Cystic fibrosis (CF) is a progressive disease affecting around 30,000 people in the US and is caused by a
mutation in a gene affecting the CFTR protein that regulates mucus composition. In airways in the lung this leads
to mucus stasis, infection, and remodeling that result in mucus plugs, poor ventilation, and progressive airway
destruction. Highly-effective CFTR modulators, now available to >90% of patients, have revolutionized clinical
care, with increases in pulmonary function via more effective mucociliary clearance. Burdensome maintenance
therapies like airway clearance treatment (ACT) require around 2 dedicated hours per day and have been
questioned by patients, families, and medical providers. In a recent CF-community survey, airway clearance was
ranked as the most burdensome therapy. Traditional studies of therapy withdrawal pose some patient risk, since
measurement is via relatively insensitive pulmonary function testing (PFT) and lung-function reductions can have
permanent consequences. Breakthroughs in structural and hyperpolarized-gas MRI demonstrate exquisite
sensitivity to CF lung disease and can be used to monitor regional and subtle changes over time, much more
precisely than PFTs, and with regional specificity. MRI provides a unique opportunity to safely evaluate ACT.
The overarching goal of our proposal is to determine effectiveness of ACT in the era of highly effective CFTR
modulators by studying structure-function relationships via MRI in patients of varying severity who have stopped
and restarted ACT. We will achieve this goal via three separate, hypothesis-driven Aims in this clinical trial:
Hypothesis 1: Patients who have relatively low structural defects will have fewer ventilation defects and higher
pulmonary function, and these defects will relate to frequency of ACT usage. Specific Aim 1: To perform UTE
and hyperpolarized Xe MRI in 30 CF patients aged 12-21, approximately 15 of whom have self-withdrawn ACT,
to regionally characterize obstructive severity and correlate regional structural lung abnormalities (via UTE
FLORET MRI) to functional deficits (via Xe MRI)
Hypothesis 2: Patients who have self-withdrawn ACT after initiation of effective modulators will demonstrate
increases in regional ventilation after reinitiating treatment, with greater ventilation increases in patients with a
higher level of lung abnormalities. Specific Aim 2: To perform a stepwise ACT re-initiation trial in fifteen 12-21
y.o. patients who have self-withdrawn airway clearance treatment (defined as ≤ 3x/week). UTE and Xe MRI,
spirometry, and multiple-breath washout will be performed at baseline, after increasing treatment to 7x/week for
1 week and then 14x/week for 2 weeks, with daily logging to aid compliance and study engagement.
Hypothesis 3: Patients who currently use 2x daily ACT and have few lung abnormalities on MRI can reduce to
1x daily or less, with no significant functional changes in the lung. Specific Aim 3: To perform a stepwise ACT
withdrawal trial in fifteen 12-21 y.o. patients who have low MRI abnormalities and high FEV1. Patients will be
studied at baseline, after decreasing ACT to 7x/wk for 1 week, and after decreasing ACT to 3x/wk for 1 week.

Public health relevance
PROJECT NARRATIVE New therapies for cystic fibrosis (CF) have revolutionized clinical care; patients and providers both wish to reduce time-consuming daily maintenance therapies like airway clearance treatment (ACT) that require around 2 dedicated hours per day. Breakthroughs in imaging lung structure and function via MRI allow us to monitor subtle changes in mucus plugs and ventilation, providing a unique opportunity to safely evaluate ACT. We will determine the effectiveness of ACT using MRI via a clinical trial in patients on highly-effective therapies who have stopped and restarted ACT.